International Congress of Human Genetics 2022

The International Federation of Human Genetics Societies (IFHGS) was formed in 1996 “to
provide a transparent structure to facilitate communication throughout the international
community of human geneticists” as well as provide a “forum for organized groups dedicated
to all aspects of human genetics, including research, clinical practice, and professional and lay
education.” A major activity of the IFHGS has been to oversee the International Congress of
Human Genetics every five years. This coming year (delayed one year due to COVID-19) the
14th ICHG will be held in Cape Town, South Africa. The meeting will be co-hosted by African
and Southern African Societies of Human Genetics and as the first ICHG in Africa will highlight
the need to increase diversity in human genetics studies, as Africa harbors more genetic
variation than the rest of the world combined. This meeting will, therefore, be important in filling
a major gap in inclusivity in human genetics research.
As the premier international human genetics meeting the ICHG will promote the sharing of the
latest genomic and clinical findings to a broad base of attendees. A major focus of the proposal
is to support junior researchers from low- and middle-income countries to participate so as to
develop their skills and knowledge and promote the development of collaborations that can
enhance genomic research globally. Sessions will include both research and clinical findings
as well as defining ethical research practices that are inclusive and sensitive to local and
diverse circumstances, with the intent of encouraging more people to become involved in
genetics research as investigators and subjects. Other topics to be covered in sessions will
include complex disease genetics, genetic services, genomic informed therapies, globalization
of genetics and genomics research including human population genetics, and the future of
genomics with an emphasis on novel bioinformatic and computational methods. Although it is
anticipated that all speakers will be in person, we have developed a hybrid delivery model so
that people can attend talks remotely, increasing the reach of the meeting.
Invited keynote speakers include Carina Schlebusch from Sweden, Shomarka Keita from the UK
and Egypt, Mayana Zatz from Brazil, Fowzan Alkuraya from Saudi Arabia and Nicole Soranzo
from the UK.

Public health relevance
The International Congress of Human Genetics (ICHG), held every five years, is the premier international meeting for human geneticists. The upcoming meeting, co-hosted by the African and Southern African Societies of Human Genetics, will be the 14th ICGH and the first to be held on the African continent at Cape Town, South Africa. This venue will serve to emphasize studies of human origins and genetic diversity and how this knowledge can enrich our understanding of the genetics of human populations and diseases. The current proposal will support this meeting and provide an opportunity to engage researchers from around the world with the intent of developing more and more fruitful collaborations that can be used to increase our understanding disease risk and its translation into clinical medicine for all peoples.